Autophagy in aging: testing geroscience in Alzheimer's disease

Project Summary
This is the revised second competing renewal of a Program Project (PP) focused on investigating the role
that age-related changes in autophagy play in the functional alterations and inefficient stress response of old
organisms. The programmatic approach has allowed us to establish previously unknown connections between
autophagy, an essential component of the proteostasis network, and key cellular processes in biology of aging
such as metabolism, immune response/inflammation and the stress response. The expansion of our team
of experts and the conceptual and technical maturation of the program have placed us in an ideal position to
contribute to test the Geroscience hypothesis that aging is the major risk factor for common chronic diseases
and that modulating processes that contribute to aging could set the basis for new interventions to ameliorate
aging-related disorders. We propose to use modulation of autophagy as a way to prevent or delay
proteotoxicity and proteostasis loss associated with Alzheimer’s disease and related dementias (AD/ADRD).
The components of the PP are four Projects involving 8 faculty members from 6 academic departments and
four Cores that provide support to the research activities of the four projects. The projects share ideas,
techniques and experimental models. Completion of aims in each project requires participation of members from
several of the Projects and Cores. The PP activities are reviewed periodically by the executive committee, and
an internal (Einstein Faculty) and external (faculty at other institutions) Scientific Advisory Committee.
The long-term goal of the PP remains testing the overall hypothesis that impairment in autophagy in elders
mediates the functional deterioration and increases vulnerability to proteotoxicity associated with diseases, in
this case AD. Building on the novel findings of the previous period, we propose now the following specific aims:
1) to determine the impact of AD-associated proteotoxicity on proteostasis and activity of three main autophagic
pathways CMA (P1, P3), MA (P4, P3) and eMI (P1, P2, P3) in peripheral tissues (liver, adipose tissue, pancreas,
skeletal muscle) (P1, P4) and the immune and hematopoietic systems (P2, P3). 2) to determine the contribution
of lymph in the transference of the aging and AD-related signature of brain proteotoxicity to peripheral tissues
(P1, P2, P4); 3) to determine the impact of loss of autophagy-dependent proteostasis in peripheral tissues (P1,
P4) and the immune system (P3) on AD-related proteotoxicity progression and 4) to analyze the effect on AD-
related proteotoxicity of genetic (P1, P3), chemical (P1, P3, P4) and dietary (P2, P3, P4) interventions that
enhance/restore normal autophagy in old organisms. These studies will require the synergistic cooperation of
groups with expertise in aging, AD-related proteotoxicity, autophagy, proteostasis, dendritic cell function, T cell
biology, hematopoiesis, lymph, lipid and glucose metabolism, nutrient sensing, medicinal chemistry, advanced
high-resolution and in vivo imaging, drug development, and data analysis and integration.
Relevance: We explore the novel concept that interventions to restore/enhance autophagy could be applied as
anti-aging strategies to prolong health-span and ameliorate AD-related proteotoxicity. Our studies may ultimately
provide pre-clinical evidence of the value of autophagy targeting in the treatment of AD/ADRD.

Public health relevance
Narrative Aging has been known to be a common risk factor to the large group of age-related disorders, including Alzheimer’s disease and related dementias (AD/ADRD). However, the mechanisms by which aging increases vulnerability to the toxicity of proteins related with AD remain unknown. This Program Project aims at answering this question building in the multidisciplinary team assembled (with expertise in biology of aging, neurodegeneration, lysosomal biology, metabolism, nutrient sensing, immunology, stem cells, medicinal chemistry, drug development and advance imaging procedures), the programmatic approach and the series of tools, resources and models developed by the team in previous periods. We will analyze if the age- dependent changes in autophagy are behind the aggravating effect of aging in AD-related proteotoxicity and test if preventing autophagy deterioration with genetical, chemical and dietary intervention is beneficial in this context. Our studies may ultimately lead to fundamental insights in understanding, treating or preventing AD and other common diseases related with loss of proteostasis that affect our elders.